BIOLOGICAL SPECIMENS/PERSONS AT HIGH RISK OF CANCER

The purpose of this contract is to provide support services to the Epidemiology and Biostatistics Program (EBP), Division of Cancer Etiology (DCE), National Cancer Institute (NCI), in order to maintain the existing EBP inventory of biological specimens and to receive, process and store new samples as they are collected.